COPDHeart: Improving Cardiovascular Health Among Black Adults with COPD

PROJECT SUMMARY
Cardiovascular disease (CVD) is a leading cause of hospitalization and death in patients with chronic obstructive
pulmonary disease (COPD), especially among Black adults with COPD. Black adults with COPD carry a
disproportionate CVD risk factor burden compared to White adults, with higher diabetes and hypertension
prevalence, lower physical activity levels, greater proportion of actively smoking individuals, and disparities in
guideline concordant statin therapy. Black individuals with COPD describe several barriers to engaging in CVD
risk reduction. For example, the complexity of COPD care leaves less time in clinic visits to proactively discuss
CVD prevention. Breathlessness limits physical activity, a key strategy to improve COPD outcomes and
decrease CVD risk. Black adults also face socially determined barriers and distrust in the health system. Prior
behavioral interventions have successfully engaged Black adults in CVD risk reduction but are not designed to
meet the unique needs of patients with COPD. Interventions to prevent CVD that simultaneously meet the needs
of COPD patients and the Black community are urgently needed. The overarching goal of this proposal is for me
to become an implementation scientist poised to lead clinical trials improving health equity. To accomplish this,
I will conduct mentored research to adapt existing interventions for CVD risk reduction in Black communities into
a novel multicomponent behavioral intervention called COPDHeart. COPDHeart will be tailored to the needs of
Black patients with COPD to increase the uptake of evidence-based Life's Essential 8 cardiovascular health
recommendations put forth in an American Heart Association Presidential Advisory. To accomplish this, I will in
Aim 1, identify barriers from patients, providers and interventionists to engaging with a multicomponent CVD
prevention intervention for Black adults with COPD; in Aim 2, iteratively refine the COPDHeart intervention with
user-centered design; and in Aim 3 determine the feasibility, acceptability, and preliminary effectiveness of
COPDHeart in a pilot clinical trial. I will combine didactics with experiential learning and mentorship to develop
expertise in stakeholder-engaged research methods, behavioral intervention design, clinical trials, and
implementation science. I have engaged an interdisciplinary mentorship team (Drs. Monika Safford, Fernando
Martinez, and Neeta Thakur) and focused content advisors (Drs. Riffin, Benzo, Schoenthaler, Peña, and
Banerjee). The results of this project will inform a large-scale randomized controlled trial of COPDHeart. This
proposal will result in an innovative intervention focused on CVD risk reduction among Black patients with COPD,
a population that has disproportionate risk of adverse outcomes. Given that comorbid COPD and CVD contribute
to significant morbidity and mortality, especially among Black adults, this proposal has the potential for
substantial public health impact. My planned training will allow me to gain expertise in stakeholder engaged
research that is crucial for my long-term goals to become a leading clinical researcher and implementation
scientist focused on health equity in COPD.

Public health relevance
PROJECT NARRATIVE Black individuals with chronic obstructive pulmonary disease (COPD) are at high cardiovascular (CVD) risk. We will engage stakeholders to design and pilot test the first intervention to reduce CVD risk and improve quality of life specifically among Black people with COPD. I will become an expert in implementation science, ready to test interventions to improve health equity in COPD outcomes.